Carolina Population Center Development Core

PROJECT SUMMARY/ABSTRACT
The Development Core is designed respond to the challenges of conducting population science
research at the highest levels by investing in developing the human capital of population
scholars and creating a culture and structure that contribute to the development of innovative
interdisciplinary, high-impact population science research projects. Given the importance of the
early stages of the career, many of the Core's activities focus on junior faculty, as part of a
multi-dimensional program of mentoring. Seed grants and sustained engagement of mentors
throughout the grant proposal writing, submission, review, and revision processes are key
components. More generally, support from an engaging and innovative Development Core can
also be critical as mid- and senior-level faculty pursue new ideas and continue their career-long
developmental trajectories as scholars. The Development Core focuses on multiple activities.
One is mentoring Early Stage Investigators (ESIs) in the preparation of competitive grant
proposals through the mechanism of our regularly scheduled Grant Proposal Development
Group (GPDG) that offers structured support for the preparation of NIH applications across the
calendar year. A second is creating a Biological/Cognitive Technical Experts (BCTE) program to
advise our faculty fellows, and particularly our ESIs, on key issues of judicious measurement
and careful use of data that will be critical for proposal development and research productivity in
the interdisciplinary space of population dynamics. Additionally, we will start a new Workshop
for Innovation and Lightning-speed Discovery (WILD) program, which will facilitate the rapid
development of new ideas and collaborations for CPC fellows at all stages of the research life
course. Finally, we will provide a range of opportunities for CPC and external population
scientists to present their work and to learn about the work of others at UNC and beyond. A key
component of our Development Core over the next five years is the attention we have given to
designing programs and mechanisms that will be as responsive as possible to the timely needs
of researchers as they evolve and that will adjust in focus as needs change over the career
trajectory.